Pediatric Heart Network - The Hospital for Sick Children, Toronto

Project Summary
The Hospital for Sick Children (SickKids), in Toronto Canada, is one of the largest children’s hospitals in North
America, with a world-renowned program in heart diseases in children. The SickKids Labatt Family Heart
Center is a leader in research in heart disease in many areas; especially in large research studies that require
the high recruitment of specialized patient populations. SickKids has been an active and productive member of
a group of child heart disease research centers called the Pediatric Heart Network (PHN) since its inception 15
years ago. SickKids is an excellent team member for this network in terms of recruitment of patients and
getting high quality results. SickKids members have greatly contributed to the PHN’s research into congenital
heart disease and acquired heart disease, and now will lead one of the studies. It has many special features
that help it to contribute to the studies, and also some special new initiatives that can help the network to move
in new directions.

Public health relevance
Project Narrative The Hospital for Sick Children (SickKids) in Toronto, Canada, is one of the largest children’s hospitals in North America, with a world-renowned program in heart diseases in children. SickKids became a member of the Pediatric Heart Network (PHN) 15 years ago and has greatly contributed to the PHN’s research program and mentorship of new investigators. With SickKids’ drive for innovation, expertise, facilities and resources, and strong track record of productivity and leadership in multi-institutional studies, the PHN is able to successfully carry out their clinical research programs so that children with heart disease can receive high-quality, evidence-based care.